Thymic and Peripheral Aspects of T Cell Aging and Rejuvenation

OVERALL- Abstract
Infectious disease, cancer, and autoimmune disorders affect hundreds of millions of older adults. They
reduce length and quality of life across the globe and inflict a massive economic burden on society, as vividly
exemplified by the SARS-CoV-2 pandemic, that has claimed 93.1% of its victims amongst those 50 years and
older, and 74.4% in those 64 and older. Yet, despite decades of research, restoring protective immunity in
older adults has remained elusive. One critical factor contributing to age-related immune decline is a loss of
naïve T (Tn) cell numbers and function, and their rejuvenation is highly desirable in order to enhance protective
immunity and overall healthspan in older adults.
The renewal of this T cell Rejuvenation Program Project is centered on two key questions: (1) why do Tn
cell numbers and function deteriorate with age; and (2) what can be done about it? The premise of the program
is that Tn cell aging is multifactorial and that it can only be resolved by targeting multiple defects. Thymic
involution and the resulting decline in T cell production is the earliest event leading to immunosenescence.
This reduction is compounded by a decline in bone marrow function, as well as by defects in Tn cell
maintenance and function in the periphery. These deficiencies combine to erode the ability of the older immune
system to detect and eliminate infectious agents and neoplastic cells, and to properly guard against
autoimmunity. In the first program period, we strongly confirmed our initial hypotheses that lymphoid organ
stromal elements deteriorate earlier than previously thought, and in a manner to decisively erode immunity,
with aging. We will build on the synergy and success of the initial program period, where discoveries in one
project are critically informing science in others, and continue to identify mechanistic reasons behind reduced
central and peripheral lymphoid organ function with aging. We will then develop combined strategies to
ameliorate these defects to improve immune defense in the elderly. Our hypothesis is that mechanistic
dissection of defects in both thymic production AND peripheral Tn cell maintenance is required to devise and
test effective interventions for T cell rejuvenation in the elderly.
Three integrated projects led by experts in the field, supported by four cutting-edge cores, will test this
hypothesis and achieve the following Program Goals: 1. Define mechanistic changes in primary and secondary
lymphoid organ aging; 2. Determine the endogenous regenerative capacity of thymic and secondary lymphoid
organ stroma over the lifespan; 3. Relate the progression of murine thymus, lymph node (LN) and T cell aging
phenotypes to humans; and 4. Devise and test rejuvenation strategies to improve thymopoiesis, T cell survival
and peripheral T cell maintenance and function, so as to enhance protective immunity.
Over this support period, the above goals will provide a wealth of basic knowledge that will be translated to
preclinical models and be poised for translation to older adults.

Public health relevance
OVERALL- Narrative Older adults are disproportionally sensitive to infection and also suffer from elevated levels of cancer and of certain types of autoimmunity. A decline in immune function decisively contributes to this vulnerability, and a decline in T cell function and maintenance is responsible for much of that decline. This Program is designed to continue to significantly contribute to fundamental knowledge of T cell aging, but more importantly to yield one or more combined interventions that improve immune defense against infection in aged mouse models, paving the way for interventions to improve T cell immunity and healthspan in older humans, providing also for substantial health care and overall economy savings and benefits.